Role of B cell activating factor in non-infectious complications of common variable immunodeficiency

Project Summary
The goal of this proposal is to support the PI’s development into an independent patient-oriented researcher
with expertise in common variable immunodeficiency (CVID) and B cell biology. The PI will be mentored in all
aspects of the proposal and receive training in systems biology approaches to human immunology research.
Candidate - The PI holds MD and PhD degrees, has completed internal medicine residency and
allergy/immunology fellowship at Mount Sinai Medical Center, and has been appointed Assistant Professor in
Department of Medicine at the Icahn School of Medicine at Mount Sinai. He has joined the laboratory of Dr.
Charlotte Cunningham-Rundles and his preliminary work defined the immunological characteristics of CVID
non-infectious complications. Elucidating pathogenesis of these complications is the focus of this proposal.
Research – CVID is the most common symptomatic primary immunodeficiency. Its greatest morbidity and
mortality results from non-infectious complications, namely autoimmunity (AI) and lymphoid hyperplasia (LH).
The PI has previously detailed the cellular characteristics of pulmonary LH underlying interstitial lung disease
(ILD) in these patients and defined clinical and laboratory associations of these complications. Recently, the PI
found B cell activating factor (BAFF) elevated in the CVID patients with progressive AI and LH and the cytokine
to be produced locally in the lungs of patients with ILD. Also, BAFF receptor (BAFF-R) expression and
signaling is localized to follicles within LH, B cell maturation is most profoundly arrested in CVID patients with
AI and LH, and apoptosis resistance of the persisting immature B cell subsets is mediated by BAFF. We
hypothesize that AI and LH result from excessive BAFF-R signaling in immature B cell subsets in CVID.
Career Development - The primary mentor (Dr. Cunningham-Rundles) is the David S. Gottesman Professor
of Immunology at Mount Sinai and is an international authority on CVID. She runs the NIH-funded lab in which
the PI will be based and directs the large clinical immunology practice from which study subjects will be
recruited. Co-mentor Dr. Andrea Cerutti is an expert in T cell-independent activation of B cells via cytokines
such as BAFF and is a Professor of Medicine at Mount Sinai. Additional advisory committee members are
respected investigators with diverse expertise that will supplement the candidate’s research mentorship and
career development. The candidate will also benefit from the collaborative research environment of the Icahn
School of Medicine at Mount Sinai and complete coursework in bioinformatics and systems biology.
Synopsis – Drawing upon a focused research approach, expert mentorship, and a strategic educational plan,
this proposal details a 5 year training program for an academic career in primary immunodeficiency and human
B cell biology. At the conclusion of training, the PI will be positioned to become an independent physician
scientist with expertise in CVID, BAFF biology, and high throughput human immunology research methods.

Public health relevance
Project Narrative Common variable immunodeficiency (CVID) is the most common symptomatic primary immunodeficiency. Approximately 50% of CVID patients develop autoimmune and lymphoproliferative complications, which are the greatest cause of morbidity and mortality because there are no effective treatments. This work will study the cytokine B cell activating factor and its relationship with the B cell maturation arrest that defines CVID in order to understand why these complications occur in the hope of inspiring novel therapeutic approaches.